The effects of environmental exposures on semen quality and the sperm epigenome

PROJECT SUMMARY
Infertility is a common condition affecting as many as 15% of couples in the United States. Despite its
prevalence, little is known about the determinants of infertility overall, or on modifiable risk factors for the male
and female contributions to infertility. Male factors (commonly defined clinically as abnormalities in
conventional semen quality parameters) are implicated in as many as 58% of cases, with an additional one
third of cases attributed to both male and female factors. Genetics have been shown to account for a small
percent (10-15%) of male infertility, indicating that lifestyle factors and environmental exposures likely play a
vital role in the majority of male factor infertility cases. Compelling animal and human studies have linked
exposures to air pollution with altered semen quality. A recent review and a recent meta-analysis of the human
epidemiologic data both concluded that air pollution has been associated with various measures of semen
quality, but both pointed to issues of comparability, consistency, and quality in the existing literature. Concerns
have also been raised regarding the impacts of environmental exposures to endocrine disrupting chemicals
(EDCs), including phthalates, flame retardants, pesticides, volatile organic compounds (VOCs) and polycyclic
aromatic hydrocarbons (PAHs) as well as the implications of exposures to multiple chemicals simultaneously.
Although the results of this literature are compelling, a number of important research gaps remain. To date, no
study has comprehensively examined the impact of multiple environmental exposures from a wide variety of
sources among groups of young, otherwise healthy men, and little is known regarding the potential epigenetic
changes these exposures may make to spermatozoa that may lead to adverse health effects in later
generations. Our proposed study will address a number of these limitations, while taking advantage of newly
available mobile monitoring devices, novel outcome measurement techniques, and newly developed real-time
exposure monitoring and passive personal samplers to improve exposure assessment. We will leverage these
combined technologies in the Growing Up Today Study (GUTS), a prospective nationwide cohort of young
adults followed since early childhood. Ambient and in-home measures of air pollution will be assigned
throughout spermatogenesis and personal exposures to a wide range of EDCs will be assessed with personal
passive wristbands. We will assess the impact of multiple environmental exposures on measures of semen
quality (concentration, total count, and motility) assessed via cell phone, morphology assessed with standard
laboratory methods, and novel epigenomic markers (sperm DNA methylation). Specifically we will evaluate the
associations of ambient and indoor home exposures to PM2.5 and NO2 and personal measurements of EDCs
on semen quality (concentration, count, morphology, and motility) and assess the association of these
exposures on sperm DNA methylation patterns.

Public health relevance
PROJECT NARRATIVE Infertility is a common condition affecting as many as 15% of couples in the United States, and male factors (abnormalities in semen quality parameters) are implicated in over half of cases where a cause can be determined. Exposures to air pollution and endocrine disrupting chemicals (EDCs) during critical windows of sperm development may be an underexplored modifiable environmental risk factor. We will examine the association between high spatial and temporal resolution measures of ambient and indoor air pollution and personal measures of EDCs on semen quality and DNA methylation within sperm cells, to develop a comprehensive understanding of the potential impacts and pathways of these ubiquitous exposures.